Mechanism of cell lethality following loss of gene expression.

PROJECT SUMMARY
The goal of this project is to determine the mechanism by which cell death results from transcriptional inhibition.
The consensus model in the field posits that cell death following transcriptional inhibition results from the loss of
specific mRNA species and subsequent loss of protein. By targeting such a core cellular process, transcriptional
inhibition is thought to overwhelm cellular control and lead to unavoidable cell death. This death process, defined
as Accidental Cell Death (ACD), is not controlled by the cell and does not result from the use of defined effector
molecules. Contrary to the conventional model, we found that, rather than induce ACD, cell death following
transcriptional inhibition results from a previously undescribed regulated apoptotic signal. Furthermore, we found
that RNA Pol II degradation, rather than loss of mRNA production, resulted in cell death. Our data suggests a
new model, whereby degradation of Pol II induces a signal that leaves the nucleus and is received by the
mitochondria to initiate apoptosis. To identify genes that regulate a pro-apoptotic signal following transcriptional
inhibition, we performed a genome-wide CRISPR screen. Genome-wide CRISPR screens often fail to identify
death regulatory genes, making it difficult to elucidate mechanisms of cell death. To overcome this, we developed
a novel experimental strategy that allowed us to identify genes whose knockout modulated the cell death rate
following transcriptional inhibition. Based on the results of our screen, in Aim 1 we will test the hypothesis that
the alternative splicing regulator PTBP1 facilitates altered splicing and nuclear export of regulatory pre-mRNA,
and that this activity is required for cell death following transcriptional inhibition. We will use live cell microscopy
to establish the functional role of PTBP1 nuclear export. We will use SLAM-seq and RIP-seq to quantify PTBP1
activity following transcriptional inhibition. Our screen also identified BCL2L12 as the critical apoptotic effector
gene for transcriptional inhibition. In Aim 2, we will test the hypothesis that BCL2L12 activates apoptosis following
transcriptional inhibition in an isoform-specific manner. We will perform a series of functional genetics
experiments to characterize the role of BCL2L12 in the apoptotic response. By describing a new mechanistic
model by which transcriptional inhibition induces cell death, we will improve our understanding of how to
effectively use transcriptional inhibitors therapeutically. Ultimately, we hope our work will improve our ability to
predict which patients will best respond to transcriptional inhibitors and help identify novel treatment strategies.

Public health relevance
PROJECT NARRATIVE We currently lack the ability to predict how cancer cells will respond to transcriptional inhibitors—a drug class of major clinical and pre-clinical interest. This proposal aims to characterize an unexpected mechanism by which transcriptional inhibition induces cell death. Rational drug design and patient selection depends on comprehensively understanding how transcriptional inhibitors activate regulated cell death.